Molecular mechanism of selective HIV-1 genome packaging

Abstract
Virtually every step of HIV-1 replication as well as numerous cellular antiviral defense mechanisms are
regulated by viral and cellular RNA-binding proteins (RBPs) that recognize distinct sequence or structural
features on viral RNAs. One such interaction takes place between the HIV-1 major structural protein, Gag, and
the viral genomic RNA. Gag packages two copies of an unspliced positive strand viral genome in particles, which
are selected from a pool of cellular and spliced viral mRNAs in excess. How viral genomes are selected for
packaging and why only two copies are packaged in a single virus particle remain poorly understood.
By extension of findings from simple retroviruses, such as murine leukemia virus (MLV), it has long been
thought that HIV-1 selective genome packaging is similarly regulated by a cis-acting packaging signal, Psi (Ψ),
located within the 5’ untranslated region of the genome. However, unlike MLV, disruption of regions in Ψ only
modestly impacts packaging and regions outside of the Ψ sequence might contribute to genome encapsidation.
Thus the precise rules that govern HIV-1 selective genome packaging still remain poorly understood. HIV-1
genome has an unusually biased nucleotide composition, rich in adenosines (~36%) and poor in cytosines
(~18%). We have previously discovered that Gag binding to the HIV-1 genome is highly dynamic and undergoes
several changes coincident with its membrane binding, multimerization, and proteolytic maturation. In particular,
we found that while cytosolic Gag bound to guanosine-rich sequences, its binding preference shifted towards
sequences with adenosine-rich nucleotide composition at the plasma membrane concomitant with its
multimerization.
In this application, we propose to test the novel idea that the overall nucleotide content of the HIV-1 genome
contributes to its selective packaging. We will conduct a series of genetic approaches in which the nucleocapsid
(NC) domain of Gag is replaced by heterologous RNA-binding domains and by determining the efficiency with
which minimal genomes with A-rich vs. A-poor nucleotide content are packaged into virions (Aim 1). Through
replacement of NC by heterologous RNA-binding domains and increasing NC copy number per Gag molecule,
we propose to determine whether dimeric genome packaging is driven by specificity, affinity and avidity of Gag
towards viral RNAs (Aim 2). Overall, this project will provide novel insight into mechanisms of selective genome
packaging. Understanding this process is not only significant from a basic molecular biology standpoint but will
also impact gene therapy and CRISPR-based engineering tools which depend on retroviral systems for efficient
delivery into host cells.

Public health relevance
Project Narrative Rules of how HIV-1 selects its genome for packaging and how it ensures the specific packaging of only two copies of its genome are unknown. In this application, we propose to explore whether the unique adenosine-rich composition of the HIV-1 genome contributes to its selective packaging in virions and whether selection of a dimer is driven by affinity and/or avidity of Gag towards viral RNAs. Selective packaging of a dimeric genome is critically important for HIV-1 to maintain high genetic diversity, and as such, the proposed studies are relevant for development of better therapeutics and vaccine strategies.